Role of BDNF in Stress Effects on Ethanol Dependence-Induced Escalated Drinking

Alcohol use disorder (AUD) is a chronic relapsing disease that constitutes a major health problem for Veterans.
Stress is known to be an important contributing factor to alcohol abuse and alcoholism, and this is especially
relevant to Veterans given their high prevalence of co-occurring AUD and stress-related illnesses such as post-
traumatic stress disorder (PTSD). Despite the significance of this problem, the complex interaction between
stress and alcohol (ethanol) drinking is not fully understood. The use of animal models is critical for advancing
our understanding of underlying mechanisms and providing platforms for evaluating potential new and novel
treatment interventions for Veterans battling PTSD-AUD comorbidity. Recent work involving our established
mouse model of ethanol dependence that involves repeated cycles of chronic intermittent ethanol (CIE)
exposure led to the discovery that reduced BDNF activity in the dorsomedial prefrontal cortex (dmPFC) is
a significant neuroadaptation associated with excessive drinking. During the current funding period, we extended
this work to show that stress facilitates and enhances this dependence-related escalation of ethanol
consumption. That is, forced swim stress (FSS) selectively enhances escalated drinking in dependent (CIE-
exposed) mice while not altering more moderate ethanol intake in nondependent mice. Additionally, stress in
combination with chronic ethanol exposure was shown to magnify deficits in BDNF expression in the prefrontal
cortex. Further, we demonstrated that direct infusion of BDNF or viral-mediated overexpression of BDNF in the
dmPFC blocked dependence (CIE)-related escalated drinking. Collectively, these data support the general tenet
that reduced BDNF activity in the dmPFC plays a significant role in the ability of stress (FSS) to enhance
escalated drinking associated with dependence. As exercise is known to elevate BDNF activity in brain, we
conducted pilot studies that have demonstrated exercise attenuates dependence-related escalated ethanol
drinking, as well as attenuating the ability of stress to further enhance excessive levels of drinking associated
with dependence. With this supportive pilot data, the proposed research plan will build and expand on this work
by examining the role of BDNF in the ability of exercise to attenuate stress-enhanced drinking in dependent
mice. Specifically, this research project is aimed at utilizing our established stress-ethanol dependence (Stress-
CIE) Drinking model to examine whether exercise attenuates stress-enhanced dependence-related excessive
drinking via BDNF-TrkB receptor signaling in the dmPFC. Proposed studies will examine whether exercise
(wheel-running) blocks stress (FSS)-enhanced escalated drinking in CIE-exposed mice, as well as attenuating
reduced BDNF expression in dmPFC that accompanies excessive drinking in the Stress-CIE Drinking model
(Aim I). Another set of studies will examine whether direct injection of the TrkB receptor antagonist ANA-12 into
the dmPFC blocks the ability of wheel-running to attenuate stress (FSS)-enhanced CIE-induced escalated
drinking and whether TrkB receptor knockdown in the dmPFC via siRNA infusion produces a similar effect (Aim
II). Finally, studies will examine whether systemic treatment with the flavone derivative and TrkB receptor
agonist 7,8-DHF substitutes for exercise in attenuating stress-enhanced CIE-related drinking, and/or whether
treatment with 7,8-DHF in the absence of exercise mimics the effects of exercise in the Stress-CIE Drinking
model. Additionally, studies will examine whether these exercise-like behavioral effects are due to activation
(phosphorylation) of TrkB receptors (pTrkB) and downstream signaling molecules (pERK1/2 and pAKT) in the
dmPFC (Aim III). Taken together, this proposal addresses a highly significant and clinically important research
topic that is of great relevance to Veteran’s heath care. Results from this research project will generate new
findings on mechanisms underlying a potential novel therapeutic approach that addresses a clinically relevant
health problem - the exacerbating effects of stress that lead to harmful excessive drinking associated with
alcoholism and PTSD-AUD comorbidity - an especially significant problem for our Veterans.

Public health relevance
Alcohol dependence and alcohol use disorder (AUD), as well as stress-related disorders such as post-traumatic stress disorder (PTSD) constitute a significant health concern for our Veterans. Given that the prevalence of AUD and PTSD comorbidity is especially high in Veterans, the need to better understand how stress interacts with alcohol is critical for developing more effective treatments for this significant health problem. This research project utilizes a model in which stress further enhances escalated alcohol drinking associated with dependence. The main objective of the project is to examine brain mechanisms underlying the ability of exercise to attenuate stress-enhanced drinking in dependent subjects. The ultimate goal is to provide new insights about mechanisms underlying a promising therapeutic intervention that will aid in treatment for individuals suffering from alcohol dependence and the exacerbating effects of stress that lead to harmful drinking - an especially important and clinically relevant problem for our Veteran patients.